DISSEMINATION & TRAINING

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Dissemination of our results and training in our technologies are essential to the success of the NAC. Each year, researchers come to us for training in the Core technologies. Trainees have included medical and engineering undergraduates and postgraduates, software developers, and those writing applications based on software developed by the NAC.